Structure of the BRCA1-PALB2-BRCA2 complex

PROJECT SUMMARY
The BRCA1, PALB2, and BRCA2 proteins form a heterocomplex that is involved in the maintenance of
genomic stability, and variants of these proteins are implicated in multiple cancers. Unfortunately, the full-length
structural details for BRCA1, PALB2, and BRCA2 are unsolved which obscures a complete understanding of their
molecular mechanism of action. Our long-term goal is to understand the molecular features of the BRCA1-
PALB2-BRCA2 axis and how disease related mutants impact their structure such that better targeted treatment
approaches can be realized. The primary goal of this proposal is to produce full-length wild type BRCA1,
PALB2, and BRCA2 (along with additional protein partners BARD1, DSS1 and RAD51) to determine the
structure of stabilized heterocomplexes. Our hypothesis is that the past difficulty in solving the structure of
these core proteins is due to the presence of intrinsically disordered domains that fail to adopt a stable
conformation unless part of a larger heterocomplex. The rationale and innovation underlying the proposed
work is that cell-free expression allows small scale, versatile and rapid optimization of conditions to increase the
chances of synthesizing a full-length protein with similar solubility, biochemical and other characteristics as the
native protein. Additionally, cryogenic electron microscopy (cryo-EM) can interrogate proteins that adopt
multiple conformations or contain flexible or intrinsically disordered regions as BRCA1, PALB2 and BRCA2 are
known to possess. Two specific aims will be pursued to complete this work: 1) Express, purify, and characterize
BRCA1, PALB2, and BRCA2 complexes. 2) Determine structure of BRCA1, PALB2, and BRCA2 complexes using
single particle cryo-EM. The success of the project will hinge on recent advancements in cryo-EM and our cell-
free expression pipeline. The proposed research is significant since it will provide a flexible framework for
production and structural characterization of BRCA1, PALB2, and BRCA2 complexes. These aims directly
align with the funding opportunity NIH PAR-23-058 “NCI Small Grants Program for Cancer Research for Years
2023, 2024, and 2025” as our goal is to generate an improved understanding of multiple tumor suppressor
proteins. This basic research proposal is both a feasibility study, as well as a small self-contained research project
that can be completed in two years. More in-depth molecular phenotyping, and functional and mechanistic
insights into BRCA-related DNA repair processes are beyond the scope of the current proposal due to both
timeframe and budget. That work in combination with more detailed structural comparison of more disease
related variants would be the focus of a separate follow-on proposal. The expected outcome of this work is
the synthesis of wild type BRCA1, PALB2, and BRCA2 along with structural characterization of the BRCA1-
PALB2-BRCA2 axis. It will also lay the foundation for a workflow extending our cell-free expression pipeline
from bioenergy research into the biomedical field to permit its application toward other cancer related proteins
whose structure remain elusive.

Public health relevance
NARRATIVE Our proposed research is relevant to public health and addresses NIH PAR-23-058 “NCI Small Grants Program for Cancer Research for Years 2023, 2024, and 2025” since we aim to generate an improved understanding of the BRCA1-PALB2-BRCA2 axis. These core proteins are well documented to play a role in breast and other cancers and yet structural information remains sparse for the individual proteins and larger heterocomplex. We will combine advanced cell-free expression techniques to generate wild type and full-length proteins then perform cryo-Electron Microscopy and Native Mass Spectrometry to determine the structure of the assembled heterocomplex and resolve structures of BRCA1, PALB2 and BRCA2.